TREATMENT OF ORTHOSTATIC TACHYCARDIA

Test the relationship of hyporolemia to the severity of orthostatic tachycardia and determine if interventions that perturb volume or autonomic function will improve the hemodynamic profile in these patients. We are continuing recruitment and screening.